Prevention Science Research Training Program

PROJECT SUMMARY
This application seeks renewal of the Prevention Science Research Training Program (PSRTP). The
PSRTP was established in 2004 as a collaborative effort of the Prevention Research Center (PRC) of
the Pacific Institute for Research and Evaluation and the School of Public Health of the University of
California Berkeley. The PSRTP is designed to prepare early career researchers to apply prevention
science to the reduction of alcohol misuse, dependence, and problems. The PSRTP takes a trans-
disciplinary approach that emphasizes the professional development of early career researchers by
providing training that leads to greater (1) knowledge of the nature, etiology and consequences of
alcohol misuse, dependence and problems; (2) understanding of the spectrum of prevention
strategies and the science underlying these strategies; (3) knowledge of the methodologies and
analytic strategies relevant to the study of prevention; and (4) sophistication in techniques associated
with the implementation and evaluation of prevention programs. The overarching goal of the PSRTP
is to provide early career scientists with the knowledge and skills necessary to succeed in the highly
competitive research and academic environments that characterize prevention research. The PSRTP
has the following specific aims: (1) to deliver a core curriculum to build expertise in prevention
science as it relates to alcohol studies through a series of structured courses that address alcohol use
and misuse, etiology, methodology, responsible conduct of research, and protection of human
subjects; (2) to provide training within a trans-disciplinary environment through informal seminars
structured around content and methodological areas and through participation in research in areas
outside the trainees’ primary areas of expertise; and (3) to facilitate each post-doctoral trainee’s
development as a researcher through intensive mentorship, undertaking an independent research
project, participating in a grant writing practicum, publishing, and engaging in professional
development activities. The PSRTP achieves these aims through: (1) formal seminars; (2) intensive
individual mentoring by senior faculty; (3) development and execution of yearly Individual
Development Plans; (4) integration into an ongoing funded research program; (5) completion of an
independent research project resulting in at least two sole or senior authored papers; (6) specialized
training in qualitative and quantitative research methods and data analysis through guided study
groups, formal coursework at the University of California Berkeley, and workshops and seminars at
other institutions; (7) attending regular presentations on current research methods, topics, and
findings at seminars and roundtables at PRC that are independent of the PSRTP seminars, and (8)
participating in professional development activities.

Public health relevance
PROJECT NARRATIVE The PSRTP is unique in its multi-disciplinary focus on prevention science as it relates to alcohol misuse, dependence, and related problems. The program provides the broad, yet intense, training experiences necessary to give early career researchers the depth and breadth of conceptual understanding, theoretical and methodological sophistication, and practical knowledge and skills necessary to advance the field.